GAMMA KNIFE THERAPY IN THE TREATMENT OF PRECOCIOUS PUBERTY

The investigators will evaluate gonadotropin changes occuring in children with precocious puberty secondary to hypothalamic hamartomas who undergo gamma knife therapy.